Extensive multiplexing of protein nucleic-acid interactions to comprehensively study gene expression regulation from chromatin to mRNA degradation

Project Summary
Gene expression is tightly controlled at both the RNA and protein level by mechanisms involving chromatin
modification, transcriptional regulation, mRNA splicing, processing, translation and degradation. Each of these
processes are regulated by nucleic acid-protein interactions (DNA-protein and RNA-protein). Accordingly, there
have been tremendous efforts in the scientific community to comprehensively map these interactions, including
major international research efforts (e.g. ENCODE, RoadMap Epigenomics) focused on generating reference
maps for specific cell types. However, because these binding maps are highly specific for individual cell types,
there is a critical need to enable the generation of comprehensive genomic maps for any cell type of interest –
including primary cell types, disease models, or other rare cell populations – within an individual lab. This goal
remains challenging because existing assays can only map interactions of a single protein at a time and are
therefore prohibitively expensive.
To address these issues, this proposal will develop a highly innovative technology based on our split-pool
barcoding strategy (SPRITE) that maps multiway protein-nucleic acid interactions using high throughput
sequencing. The proposed Hi-P technology will be used to establish: (i) a highly multiplexed eCLIP-seq method
to map up to hundreds of RNA binding proteins simultaneously to their RNA binding sites, (ii) a highly multiplexed
ChIP-seq method to map up to hundreds of DNA binding proteins and histone modifications to their DNA binding
sites, and (iii) methods to map these multiple protein-nucleic acid interactions across many samples, among
these rare cell types, simultaneously.
The proposed technology represents a major advance – it will dramatically increase the scale of existing methods
and create new capabilities that are currently not possible. These tools will empower individual researchers to
generate detailed genomic datasets in specific biological and disease contexts that are comparable in size and
complexity to those generated by the ENCODE project at a tiny fraction of its cost. More generally, we anticipate
that these tools will lead to critical new insights into gene regulation and human disease.

Public health relevance
Public Health Relevancy Statement Gene expression is tightly controlled in time and space and is governed by protein-nucleic acid (DNA and RNA) interactions. There are hundreds of DNA- and RNA-binding proteins that regulate gene expression and many are mutated in disease, but we lack facile approaches to map these proteins to their DNA/RNA targets. Here we propose to develop an innovative set of tools that will give every molecular biology lab the possibility to obtain comprehensive cell-type specific protein DNA/RNA interaction maps, a necessity to understand gene expression regulation and therefore disease development.